10th Congress of Toxicology in Developing Countries (CTDC10)

Abstract The International Union of Toxicology (IUTOX) organizes the largest and most prestigious International Congress on Toxicology every three years, offering scientists, government regulators and members of industry the opportunity to learn about the latest developments in toxicological science and regulation through general scientific sessions and continuing education classes. The 10th Congress of Toxicology in Developing Countries (CTDC10) will be held April 18-­21, 2018, in Belgrade, Serbia. Toxicologists from around the world will share their recent findings and attendees will learn about the latest advances in the science of toxicology, hear from eminent international speakers and leading researchers, and be able to discuss the complex issues that arise when drugs or chemicals adversely impact humans, animals and the environment. IUTOX is seeking support from NIEHS for two types of travel fellowships. The Junior and Senior Toxicologist Travel Fellowships focus on helping scientists from developing or least developed countries attend the CTDC10 meeting to help these scientists return to their home countries in a better position to solve numerous, urgent toxicology issues. The Junior Toxicologist Travel Fellowships (12 at $750 each) will be aimed at toxicologists at an early stage of their career (under 35 years of age). A CV, abstract and nomination from home toxicology society are required. Preference will be given to applicants from developing and least developed countries. The Senior Toxicologist Travel Fellowships (6 at $1,000 each) will be aimed at toxicologists from developing countries involved in organizational activities (i.e., mentoring, promoting training and educational opportunities in areas such as risk assessment) with examples on potential for translation of toxicology issues in their own national toxicology society.

Public health relevance
Narrative The mission of IUTOX is to improve human health through the science and practice of toxicology world- wide and achieves its vision by fostering international scientific cooperation for the global acquisition and utilization of knowledge in toxicology for the improvement of human health. This occurs through sponsorship and planning of international congresses of developed and developing countries and through a variety of educational initiative including hosting continuing educational courses both associated and independent of the international congresses. Therefore, this proposal for travel support for the 10th Congress of Toxicology in Developing Countries (CTDC10) held April 18- 21, 2018, in Belgrade, Serbia, achieves these aims.